Assessing Stable Characteristics of Endocrine Function Among Boys and Girls with Prenatal Alcohol Exposure as a Novel Clinical Tool

Individuals affected by prenatal alcohol exposure (PAE) can present with a complex profile of cognitive,
behavioral, physical, and mental health problems, referred to as fetal alcohol spectrum disorder (FASD). Of
particular relevance, up to 90% of individuals with FASD may experience mental health problems over the life
course. Animal models of PAE demonstrate that alterations in neuroendocrine function serve as a fundamental
neurobiological mechanism for increased mental health problems; thus, improving or normalizing endocrine
function may provide a novel approach for improving outcomes. The primary aim of the K01 proposal is to
accelerate the candidate's learning opportunities to addresses this translational gap in knowledge through
examination of individual differences in endocrine activity in humans with PAE, and their implications for
susceptibility for mental health problems. Towards this end, the candidate's unique and independent aims
capitalize on 2 independent NIH-funded research programs: 1) 550 adolescents (33% PAE; 33% non-PAE with
drinking moms; 33% non-PAE with non-drinking moms; 50% girls; aged 9-12 years) from the Adolescent Brain
Cognitive Development (ABCD) study in the United States, and 2) 160 adolescents (50% PAE across all
trimesters; 50% non-PAE; 50% girls; aged 9-12 years) as part of the Prenatal Alcohol SIDS and Stillbirth
(PASS) birth cohort in South Africa. The K01 proposes to: A) utilize funded neuroimaging and prenatal
substance exposure data in ABCD/PASS; B) utilize funded ABCD data on hormones, puberty and mental
health; and C) collect new PASS data on hormones, puberty and mental health. Methods for assessing brain,
mental health, and puberty will be harmonized between ABCD and PASS cohorts, yet there will be distinctly
different experimental designs, each with their unique strengths and limitations. These contrasting cohort
designs and populations provide a rare opportunity for acceleration of learning opportunities as well as
advancement of our ability to identify the most important components of variance for understanding individual
differences in endocrine function in adolescents with PAE. Groups will be matched on age, sex, race and SES
within their respective cohorts. Initial findings from the ABCD cohort will inform tests in the independent PASS
sample, providing strength for interpreting generalizability of findings across diverse social, racial and cultural
environments. The candidate's training will take advantage of the rich expertise of the diverse mentoring team
to integrate central/peripheral measures of endocrine function, by bridging the fields of neuroimaging,
neuroendocrinology, salivary biosciences and biostatistics to better understand individual differences in
endocrine function. The training plan capitalizes on the central location of CHLA, and includes didactic courses
and one-on-one mentoring at USC (latent state trait modeling course), UCI (salivary bioscience course), and
UCLA (MPlus). The training plan will foster new neuroimaging expertise through learning how to integrate two
imaging modalities, as well as building expertise in salivary biosciences, biostatistics and mental health.

Public health relevance
Narrative. Animal models of prenatal alcohol exposure (PAE) demonstrate life-long hormone dysregulation as an underlying mechanism of common behavioral, cognitive and mental health problems. The present proposal addresses this translational gap in knowledge through investigation of PAE and endocrine function in humans.